The Determinants of Tobacco Relapse and Initiation Following a Period of Forced Abstinence in the U.S. Military: A Social Ecological Approach

While the military has taken steps to reduce tobacco use for the past two decades, 26.9% of new military
recruits report regular tobacco use prior to enlistment,7 and 28.5% of Airmen report regular use one year into
service. The prevalence of tobacco increases in Airmen’s first year in the Air Force despite a ban on tobacco
during the first 10 ½ weeks of training and 63.0% of Airmen being “completely confident” they will remain
tobacco free one year later.7 What is most troubling is the high rate of initiation among never users. Within the
first year of Air Force service, 20.4% of never users initiate regular tobacco use and 67.0% of former users re-
initiate, and 76.2% of this use occurs during Technical Training. These high rates of initiation/re-initiation are
occurring despite the fact that there are rigorous anti-tobacco regulations on all Department of Defense military
bases, suggesting that there is something unique about the Technical Training environment leading to this
initiation/re-initiation. To date, no studies have assessed the impact of the tobacco built environment in this
“natural experiment” of forced abstinence and rapid relapse. In addition, no studies have measured the
influence that Technical Training leadership, including Commanders, Military Training Leaders, and Technical
Training Instructors, have on Airmen’s behavior during Air Force Technical Training. Informed by the Social
Ecologic Model, the Specific Aims of this Early Stage Investigator project are to: (1) Refine existing measures
to determine knowledge, attitudes, beliefs and behaviors related to tobacco use among Airmen, Military
Training Leaders and Instructors (Phase 1). During Year 1, conduct focus groups with Airmen, Military Training
Leaders and Instructors at the 5 largest Air Force Technical Training schools (Lackland AFB, Fort Sam
Houston, Keesler AFB, Sheppard AFB, and Goodfellow AFB) to inform the adaptation and development of
measures. (2) Determine the influence of Airmen’s, Military Training Leaders’ and Instructors’, and
Commanders’ knowledge, attitudes, beliefs and behaviors related to tobacco use on Airmen’s tobacco use
during Technical Training (Phase 2). Beginning in Year 2, survey 10,000 Airmen at the beginning and end of
Technical Training, survey 200 Military Training Leaders and 190 Instructors, and conduct interviews with all
base Commanders as they turnover throughout the study at 5 Technical Training schools (N=102). (3)
Determine the impact of the tobacco built environment (e.g., number, density, proximity of tobacco retail
outlets, tobacco availability, pricing, placement, and promotion) both on and around the base perimeter on
Airmen’s tobacco use (Phase 2).

Public health relevance
Within the first year of Air Force service, 20.4% of never users initiate regular tobacco use and 67.0% of former users re-initiate, with 76.2% of this relapse occurring during Technical Training. To date, no one has assessed the impact of the tobacco built environment in this “natural experiment” of forced abstinence and rapid relapse, nor has anyone measured the influence that Air Force leadership (Military Training Leaders, Instructors and Commanders) have on Airmen’s behavior during Technical Training. In the proposed application we will take a social ecological approach to explore how characteristics of Airmen, their peers, training leadership, Air Force policies and the tobacco built environment influence high rates of tobacco initiation and re-initiation in Technical Training.